Toward measures and behavioral trials for effective online AUD recovery support

Alcohol Use Disorder (AUD) is a common and serious health condition. A growing number of people are seeking AUD recovery support via popular Online AUD Recovery Support (OARS) forums on social media platforms. OARS forums lower barriers to social support in recovery, are widely available, and show promise for improving AUD outcomes. However, as there are no rigorous clinical trials focusing on OARS forum participation, there is insufficient evidence to recommend them as effective in supporting AUD recovery. Such trials are challenging, given the variety of OARS forums and the myriad approaches to participation. My long-term career goal is to become an independent investigator and leader in development, implementation, and assessment of behavioral approaches to OARS that are effective in improving AUD recovery outcomes. To fill crucial gaps in my expertise, I have four training objectives: (1) Conceptual frameworks of AUD and AUD recovery processes, to provide strong conceptual foundations for this work; (2) Focus group methods for concept mapping and human-centered design, to collect data from OARS forum users that informs subsequent self-report scale and intervention development; (3) Advanced methods for text classification (e.g., natural language processing), to advance rigorous observational research of OARS behaviors in naturalistic settings; and (4) Clinical trial design for behavioral interventions, to develop and conduct trials that assess the effectiveness of OARS participation on AUD outcomes. I have assembled a multidisciplinary mentoring team of AUD and addiction recovery researchers with a strong track record of NIAAA funding and mentorship. My consultants provide necessary expertise in social processes of recovery, psychometrics, text classification methods, and clinical trial development and statistical analysis. The proposed K01 research builds upon my prior work focusing on patterns of OARS participation and social support. I propose an OARS Behavioral Pathway Model (OARS-BPM) to characterize observable behavior of OARS participation and social support, which are associated with development of AUD coping skills and a recovery orientation. I will develop self-report scales and corresponding text classifiers to identify latent constructs of OARS behavior. To assess and refine OARS-BPM, I will elicit focus group feedback from OARS users and apply text classifiers to characterize user behavior from public OARS forums. Based on these findings, I will conduct a pilot randomized clinical trial to assess feasibility and acceptability of an OARS-BPM based intervention to encourage structured OARS participation over 3 months.

Public health relevance
Alcohol Use Disorder (AUD) recovery outcomes can be improved through peer-based social support, but barriers to in-person support (e.g., 12-step groups) are high. Online AUD Recovery Support (OARS) forums are growing in popularity and offer convenient access to real-time social support, which may improve well-being and support transitions to in-person support, but effectiveness of OARS on improving AUD outcomes has not been studied in rigorous clinical trials. To enable rigorous testing of OARS participation—ultimately leading toward evidence-based guidelines for their use in AUD—I will develop necessary measures of OARS behavior and conduct a pilot randomized clinical trial to assess the feasibility of a behavioral intervention for OARS participation.